Next Generation Resolution of Antiviral Gene Networks

SUMMARY
As the primary mediators of the innate response to viral infection, type I interferons (IFN-I) establish an antiviral
state in both infected and uninfected bystander cells through the induction of several hundreds of interferon
stimulated genes (ISGs). The mechanisms by which the coordinated activities of these ISGs confer resistance
to diverse viruses, and the regulatory circuits that modulate their expression remain poorly understood. Working
with unique samples from individuals with hereditary syndromes of dysregulated IFN-I responsiveness, we have
identified a collection of thirty ISGs that confer resistance to diverse viruses (increased protection against RNA
and DNA viruses with both high and low pathogenic burden). We have also uncovered previously unappreciated
negative feedback mechanisms of IFN-I signaling. We have found that these regulatory circuits, as well as ISG
expression patterns, vary significantly across different cell types at steady state and upon IFN-I stimulation.
Recent technological advances now enable us to explore these cooperative ISG antiviral functions and negative
feedback mechanisms at unprecedented depth and resolution.
In the studies proposed here, we will identify subsets of ISGs sufficient to confer broad protection against multiple
viruses using a novel single cell RNA-Seq strategy. This approach provides the throughput required to conduct
complex combinatorial experiments while maintaining the high resolution to test specific hypotheses. Results
may offer new broad spectrum antiviral therapeutic strategies, which would be of particular value against
emerging viral pathogens. We will also investigate in detail the mechanisms by which IFN-I signaling establishes
a lasting imprint on cellular responsiveness to subsequent IFN-I stimulation. This recently described but
incompletely characterized phenomenon likely has important implications for successive infectious challenges
and viral susceptibilities. Combining a unique collection of clinical samples, cutting edge technologies, and
diverse and complementary expertise in immunovirology from our two laboratories, these studies are expected
to address long standing, fundamental questions in innate antiviral immunity, as well as to pioneer new directions
for developing antiviral therapies.

Public health relevance
PROJECT NARRATIVE Type I Interferon induces expression of hundreds of genes to protect against viral infection. How these genes are regulated in different contexts, and how they work together to restrict viruses is not well understood. This project will apply novel technologies to define the mechanisms that regulate the type I Interferon response and the effectors that provide broad antiviral protection.